HCV-Host Interactions During Antiviral Therapy

In contrast to large, multinational, industry sponsored clinical trials, far lower sustained virological responses (SVR) to standard of care (SOC) pegylated interferon (IFN) plus ribavirin therapy have been observed in urban clinics and in developing countries such as Brazil, where ethnicity and host factors affect the outcome of treatment. For example, induction of a small group of IFN stimulated genes (ISGs) has been shown to predict response to therapy, while genetic variation in the interleukin 28B gene predicts treatment-induced and spontaneous viral clearance and may explain why African Americans and minorities respond poorly to therapy. Thus, it is imperative to understand how IFN-based therapy works in different populations and ethnic backgrounds so as to minimize improper use of new Specifically Targeted Antiviral Therapy for HCV (STAT-C) therapies and the subsequent emergence of resistant viruses. To address this issue, we have begun a clinical trial in Brazil driven by the hypothesis that host genetics and innate antiviral responses shape the outcome of antiviral therapy. We will measure hepatic gene expression, host genetic polymorphisms, and viral kinetics, and correlate these host and viral factors with outcome of therapy. The proposed study will provide the first detailed description of IFN responses in Brazilian patients, who represent a diverse ethnic population. It will also compare the South American experience with European and North American-based clinical trials, and will delineate how SOC therapy affects host innate responses that ultimately control HCV infection. Finally, the proposed studies may lead to improved therapeutic strategies that will enhance global control of HCV by reducing the spread of resistant strains.

Public health relevance
This application seeks to determine host factors that determine whether or not antiviral therapy for hepatitis C virus infection will be successful. We will measure the level of activation of patient’s antiviral (interferon) systems and measure unique DNA polymorphisms that correlate with response or non-response to therapy. We will also correlate changes in these parameters with changes in viral load during therapy. These studies are important because we need to understand better how to effectively treat minority patients and patients in developing countries, where the disease burden due to chronic hepatitis C is greatest. More effective treatment strategies will also reduce the spread of resistant viruses throughout the world. Therefore, this proposal will contribute to more effective global control of hepatitis C.